THE ROLE OF SELENOPROTEIN SYNTHESIS PATHWAY IN ACUTE MYELOID LEUKEMIA

AML is the most common acute leukemia in adults, and it appears increasingly with age. Despite overall
improvement in the treatment of leukemia, AML still carries a devastating prognosis for elderly patients (less
than 10% of patients survive for 5 years). Thus, new therapies for AML are necessary. Using a bioinformatics
approach and a whole-genome CRISPR screening approach, we identified regulators of selenium metabolism
to be important for AML survival. Selenium is required for cells to synthesize selenocysteine, which is then used
to produce selenoproteins. Since many selenoproteins are involved in redox regulation, we hypothesized that
selenium metabolism is required for redox maintenance of AML. This hypothesis will be tested in the following
three aims. In aim 1, we will use mouse models that we have generated that have mutations in the genes we
identified in the CRISPR screen to examine the requirement of selenium metabolism in murine AML. In aim 2,
we will use a mouse model that lacks the redox regulator, which we hypothesize to be downstream of the
selenium metabolism pathway, to examine how this redox regulator promotes murine AML. In aim 3, we will
study the mechanisms we discovered in human AML patient-derived xenograft models to examine the
therapeutic potential of inhibiting selenium metabolism in AML. These genetic analyses with both murine and
human AML models should bring novel insights into how AML regulates selenium metabolism and the
therapeutic potential of targeting this mechanism.

Public health relevance
Acute myeloid leukemia (AML) is the most common acute leukemia in adults with a devastating prognosis for elderly patients. We discovered an unexpected role of selenium metabolism in AML, and we will interrogate this mechanism in animal models and patient samples to examine whether we could therapeutically target this mechanism to treat AML. Our study may lead to a novel combinatorial therapy that could deeply suppress AML.